Molecular origins and evolution to chemoresistance in germ cell tumors

PROJECT SUMMARY
Approximately 8,000 people in the U.S. are diagnosed with germ cell tumors (GCTs) each year, and the vast
majority are young men who develop testicular GCTs. Most patients are cured with conventional
chemotherapy, although 30% recur, and half of such patients ultimately succumb to their disease. Given the
long life expectancy of these patients, when death from GCT occurs, it accounts for among the greatest
number of life years lost of any non-childhood malignancy representing. Our previous studies have
demonstrated that GCTs exhibit an extreme burden of reciprocal loss of heterozygosity (RLOH) and high
degree of mitochondrial priming for apoptosis. The goal of this proposal is to dissect the molecular features
that initiate RLOH in GCTs, determine the relationship between RLOH and defect DNA checkpoints as tumors
progress, and evaluate the ability of functional assays to identify highest risk disease prior to chemotherapy
initiation. The long-term objective is to enable new mechanisms of patient stratification and identify new
therapeutic targets for chemoresistant GCTs, currently an area of unmet medical need with extremely limited
therapeutic options under investigation. This proposal is unique in that it leverages the extensive and novel
resources at both the Dana-Farber Cancer Institute/Harvard Cancer Center and the Broad Institute of MIT and
Harvard, along with an international team of collaborators, to overcome limited preclinical models of this
disease and incorporate patient-centered assays focused on human tumor samples to address the hypotheses
outlined herein. The proposed specific aims are: 1) To define the genetic defects associated with reciprocal
loss of heterozygosity in primary germ cell tumors, 2) To identify the molecular features of tumor evolution
leading to chemoresistant germ cell tumors, and 3) To assess the clinical utility of pluripotency markers as
prognostic for GCT outcomes. These studies will define the meiotic defects underlying RLOH in GCTs, identify
the secondary molecular defects that initiate lethal chemoresistance, and reveal targets for enhanced patient
stratification and therapeutic development. In addition, these efforts will accelerate development of new
computational algorithms that explore integrative molecular analyses of both the genome and epigenome to
address specific hypotheses regarding oncogenic development and progression to chemoresistance that may
have broad applicability. Finally, this project will accelerate the clinical and molecular characterization of GCTs,
explore the underlying biology driving this rare tumor type, and serve more broadly as an innovative model for
studying rare cancers.

Public health relevance
PROJECT NARRATIVE Death from chemoresistant germ cell tumors (GCTs) account for the greatest number of life years lost of any non-childhood malignancy, and the origins and evolution to chemoresistance in this disease are incompletely characterized. We have developed data identifying reciprocal loss of heterozygosity (RLOH) as a disease- defining genomic defect in GCTs, presence of apoptotic priming underlying the more typical chemosensitivity, and accumulation of RLOH as GCTs evolve towards chemoresistance. Through the use of several novel molecular techniques applied directly to patient specimens, this proposal will enable this program to develop a more complete understanding of the factors driving oncogenesis and evolution to chemoresistance in this rare cancer, with the plan to translate targets revealed through this study to therapeutic development in this area of unmet medical need.